Impact of brief daily functional resistance training on lower extremity physical performance

ABSTRACT
One of the most common, and untreated, health problems among older adults is mobility disability, observed in
nearly one in five (17.9%) of older adults. Mobility disability is typically the first disability to develop and
increases future risk for additional disabilities and death. Though the most effective treatments for mobility
disability are forms of exercise, especially resistance training (RT), they are rarely used, with fewer than 20%
of older adults meeting RT guidelines and even fewer among those with mobility disability. The core problem of
disseminating the benefits of RT to older adults is adherence. One potential opportunity to enhance adherence
to RT, which has not been tested, is to make RT programs shorter. Studies show that most of the benefits of
RT accrue with the first few sets per week, consistent with the law of diminishing utility. While traditional RT
programs for older adults, like those offered by Silver Sneakers, are typically 45 minutes three times weekly,
fewer than 5% of older adults with free access to these programs participate. Our qualitative work shows that
older adults often feel that 45 minute sessions are too challenging (e.g., “I don’t think I have the strength to do
it for 45 minutes”) and 75% of older adults we surveyed preferred a 5 minute RT to a 45 minute RT option,
assuming they were equally effective. In 2020, we set out to design a brief, home-based RT program that
would lead to both high levels of adherence and functional improvement. We called the program FAST
(Functional Activity Strength Training) and, to overcome its brevity, FAST was augmented with several
standard behavior change techniques (e.g., feedback, reminders, self-monitoring) and a novel form of goal-
setting, rarely used in RT studies, for the number of additional repetitions participants should be able to do
during the study. In FAST-1, 24 healthy older adults were prescribed 30 seconds of squats and push-ups each
day and given no personal supervision. Over 6 months, they performed the exercises on 73% of days and
showed large increases in squat and push-up performance (Cohen’s d > 1.0). In FAST-2, we randomly
assigned 97 older adults with mobility disability, and those assigned to 30 seconds each of chair stands and
steps onto a stepper each day completed exercises on 81% of days (5.7 days per week) and improved their 5
time sit-to-stand test (-2.8 seconds, Cohen’s d=0.53), 30 second chair stand test (+4.2 repetitions, d=1.1) and
One Leg Stand test (+3.7 seconds, d=0.40), versus controls. In this multicenter study, we will randomly assign
360 older adults with an SPPB score < 8 to 6 months of daily FAST or to a delayed control group. We will test
the impact of FAST on physical performance, walking ability, falls and functional limitations. We hypothesize
that FAST will improve these measures more than controls, and that those with greater adherence and
perceived effort will improve the most. By rigorously testing FAST, we hope to change the paradigm of RT
prescription from “More is better” to “What will people do that works?” and, if FAST proves superior, a future
study will test whether FAST leads more older adults to do RT and, thereby, improve the public’s health.

Public health relevance
Project Narrative Though fewer than 20% of older adults perform the recommended amount of resistance training, systematic reviews show that it has a strong effect on improving strength and physical function. While briefer resistance training sessions, which older adults prefer, have been proven to increase strength, no Phase 2 efficacy studies have been conducted to understand their impact on improving physical function, including mobility. If this trial shows that a brief, daily resistance training program improves lower extremity performance and mobility, this study may alter guidelines for resistance training and, by making programs shorter, potentially improve their uptake by older adults and, in doing so, improve the public’s health.